TREATMENT OF PATIENTS WITH ACUTE LYMPHOBLASTIC LEUKEMIA WI/ UNFAVORABLE FEATURES

Patients with poor risk all: Ages 1-9 with initial WBC> 50,000/UL or ages between 10 years and 21 years are eligible. All patients will receive BFM induction. A day 7 marrow calssify subjects as either rapid early responders. Slow responders whose cells are CD19+ will be randomized to continue on BFM induction with and without the addition f immunotoxin (B43-PAP)